16/24 Healthy Brain and Child Development National Consortium DIVERSITY SUPPLEMENT

Abstract
Substance use among pregnant women is a substantial public health concern that can result in
adverse outcomes in offspring. The aims of the Healthy Brain and Child Development (HBCD)
parent grant are to: 1)
examine behavioral, cognitive, biological, social, and emotional aspects
of child development from prenatal to 10
years old and 2) examine the impacts of
sociodemographic factors, stress and mental health, genetics, and
prenatal substance exposure
on child development. However, the parent project is focused on data collection and on the
developmental periods of infancy and
childhood. The proposed work will use existing data from
the F.U.T.U.R.E.S. study (“Following Urban Teens: Unique and Resilient at Every Step,
DA021059
), which examined the impact of prenatal substance exposure on behavioral and
brain development in adolescence. In Aim 1 of this proposed supplement, the Candidate will
examine interactions between PDE and caregiver mental health on behavioral outcomes in
adolescence. We hypothesize that the combination of PDE and poor caregiver mental health
(characterized by
symptoms of depression, anxiety, and/or stress) will produce the worst child
outcomes. Exploratory analyses will probe whether effects vary as a function of type of
substance or duration of use. In Aim 2, the Candidate will examine interactions between PDE
and caregiver mental health on adolescent brain
structure and function. We hypothesize that the
combination of PDE and poor caregiver mental health will be associated with variations in brain
volume and cortical thickness compared to individuals with either one risk-factor alone or no risk
factors. This work will
provide a better understanding of maternal mental health and caregiver
environment that influence many aspects of child development. As a full-time faculty researcher,
the Candidate does not have the opportunity to
explore research interests outside of the parent
project and pursue training that would make her
a competitive prospective graduate student.
Ultimately,
this training project will help accelerate the Candidate’s transition to graduate school
and her research career trajectory.

Public health relevance
Project Narrative Substance use among pregnant women is a major public health concern that impacts child and adolescent outcomes. The proposed supplement examines the interaction between prenatal drug exposure and maternal mental health on adolescent behavioral and mental health outcomes and brain development. This work will provide a better understanding of the effects of pre- and postnatal factors that impact developmental outcomes in adolescents.